Improving extraction success of FFPE samples with automated and reliable microfluidic sample preparation

Abstract
Genomic sequencing data is suitable for informing clinical decisions and advancing precision
medicine. While fresh-frozen tissues are the gold standard for next-generation sequencing, only
fixed paraffin-embedded (FFPE) tissue blocks are widely available in clinical workflows. The
fixation process enables a readily available, cost-effective resource repository with preserved
morphology and cellular data. However, extraction after fixation frequently yields low quantities of
degraded nucleic acids (NAs). The quantity and quality of nucleic acids can be improved during
extraction, however current workflows remain highly dependent on manual methods that are
labor-intensive, time-consuming, and vary in quality by operator skill.
Extracting nucleic acids from FFPE samples requires robust protocols with the ability to maintain
consistent performance. The translation from manual to reliable automated methods will be crucial
to advancing the field. In this SBIR project, we automate extraction of nucleic acids from FFPE
samples using an innovate microfluidic solution. Our method will perform deparaffinization, lysis,
and decrosslinking of FFPE tissue curls without the need for pipet-driven mixing,
microcentrifugation, or filtration; NAs will then be purified with a microfluidic magnetic bead
technology. In a subsequent Phase II project we will fully automate this workflow on our platform
for automated, cartridge-based sample prep.

Public health relevance
NARRATIVE In this project Redbud Labs will develop key microfluidic components for automated extraction of nucleic acids from raw formalin-fixed paraffin-embedded (FFPE) tissue sections. The goal is the development of an automated system that will maximize the integrity and yield of DNA extracted from these samples.